Pre-clinical development of SPY-DYS45-55, a CRISPR/Cas9 platform for Duchenne muscular dystrophy

MyoGene Bio is a startup dedicated to developing cutting edge genetic therapies for muscle
diseases. In this proposal, the company will advance development of our potential therapeutic,
SPY-DYS45-55, a CRISPR/Cas9 gene editing platform for Duchenne muscular dystrophy (DMD)
in conjunction with research partners at UCLA. Duchenne is a devastating muscle wasting
disorder with no cure that is caused by out-of-frame mutations in the DMD gene. SPY-DYS45-55
removes a mutational hotspot in DMD to restore the reading frame for half of all Duchenne
patients by generating an in-frame exon 45-55 deletion. This deletion is associated with a very
mild phenotype in human Becker muscular dystrophy patients. Systemic delivery of gene editing
platforms to muscle represents a significant challenge. Certain serotypes of recombinant adenoassociated
virus (AAV) have tropism to skeletal muscle and heart. However, the immune
response to the virus prohibits repeated administration of AAV. Furthermore, pre-existing
immunity in some individuals (anticipated to be present in up to 70% of adults), precludes their
eligibility to take advantage of this treatment. The goal of this Fast Track proposal is to devise
strategies to overcome these challenges. In Phase I, we will determine an optimal
immunosuppression regimen that allows redosing of AAV in order to improve the efficacy and
applicability of SPY-DYS45-55. In Phase II, we will assess the long-term functional benefit,
toxicity, and off-target activity from single or multiple injections of AAV-SPY-DYS45-55 in our novel
mouse model containing a mutated human DMD gene. Ultimately, these studies will generate
the initial pre-clinical data needed to translate SPY-DYS45-55 to patients with Duchenne muscular
dystrophy.

Public health relevance
In this proposal, MyoGene Bio will further develop our product, SPY-DYS45-55, a gene editing platform that permanently removes genetic mutations for approximately half of all Duchenne muscular dystrophy patients. Since Duchenne has no cure and only limited treatments, SPYDYS45- 55 offers a potential therapy for a large cohort of Duchenne patients. Additionally, the knowledge that will be obtained about redosing adeno-associated virus (AAV)-SPY-DYS45-55 will have far-reaching implications for improving the efficacy and safety of other AAV-based therapies.